Intergrated Biorepository of H3Africa Uganda

Summary/Abstract
Background: The availability of high quality well annotated biological and environmental
specimens for research purposes requires the development of standardised methods for
collection, processing, long-term storage, retrieval and distribution of specimens that will
enable their future use for research.
For this reason, the NIH (in 2013) together with Makerere University established the Integrated
Biorepository of H3Africa in Uganda (IBRH3AU), a state-of-the-art facility for sample
collection, processing, storage, retrieval and distribution for genomic research for the H3Africa
Consortium and other researchers. In the past 10 years, the IBRH3AU has stored samples
from both H3Africa researchers and other researchers. The biorepository has been
instrumental in the response to COVID-19 through establishment of COVID-19 biobank that
was key in providing samples for rapid evaluation of COVID-19 diagnostic Kits and availing
samples to the biotech companies developing COVID-19 vaccines, therapeutics and
diagnostics in Uganda and beyond.
As the H3Africa project draws to the end, the Uganda biorepository has critical pending
unfunded activities. The overall goal of this administrative supplement request is to ensure the
key pending activities are completed. H3Africa projects within Eastern and Central Africa who
are finalising with project activities will be able to complete sample deposition to the
biorepository. Through the supplement the biorepository will be able to continue processing,
storage and distribution of samples to researchers. In addition, there is need for additional
funding to analyse the samples of environmental exposure that have been collected and
stored in the Uganda Biorepository. Due to COVID-19, the procurement of equipment for
analysis of the environmental exposure samples was delayed. The supplement will be useful
in further consolidation of our sustainability plan
Approach: (a) The Uganda H3Africa Biorepository will use the funding from the supplement to
continue to support the H3Africa researchers to finalise sample shipment, processing, storage
and distribution. Quality controlled and assured biorepository services will be offered as per
ISO 20387 biobanking standard, ISBER best practices and standards, in line with H3Africa
Data and Biospecimen Accession (DBAC) policies, (b) In addition to existing and implemented
protocols for genomic analyses (Nucleic acid [DNA and RNA] extraction and purification from
blood and its derivatives), protocols, Standard operating procedures and practices have been
developed and implemented for collecting and storage of samples for environmental
exposures (tobacco smoke, trace elements, perfluoroalkyl and polyfluoroalkyl substances,
metabolites of pesticides, toxins from mold, polycyclic aromatic hydrocarbon metabolites,
volatile organic compounds, etc.) The stored samples are yet to be analysed. The supplement
will provide us with a chance to analyse these samples and reveal the extent of the burden in
this setting. (c) Through continued implementation of our business plan to ensure
sustainability, the biorepository will remain a true scientific transformatory resource beyond
H3Africa project.
Expected Benefits:
• Ensure logical conclusion of H3Africa project activities as the biorepositories
collect and store the remaining samples.
• Enable analysis of stored samples of environmental exposures to estimate the
magnitude of the problem in Uganda
• Continue to consolidate the sustainability plan for the Uganda Biorepository

Public health relevance
Project Narrative The Integrated Biorepository of H3Africa in Uganda (IBRH3AU) is a state of the art facility funded by the U.S NIH (2013) to support sample collection, processing, storage and retrieval for genomic research under the H3Africa Consortium. The overall goal of this supplement is for IBRH3AU to obtain funds to complete pending activities of H3Africa projects within Eastern and Central Africa, and use the newly acquired equipment to analyse stored samples of environmental exposure, and continue to consolidate our sustainability plan. This should create an ISO 20387 accredited, self-sustaining bio- specimen and environmental regional repository with ISBER standards.